Vagal nerve stimulation to probe inflammation and brain in posttraumatic stress

Abstract:
Rates of posttraumatic stress disorder (PTSD) are high among combat Veterans with estimates of PTSD within
Iraq and Afghanistan veterans at nearly 17% of active duty and over 24% of reserve service members that screen
positive for PTSD. Studies from the current and prior wars have demonstrated that mental disorders, in particular
PTSD, are associated with higher rates of: 1) physical symptoms, 2) chronic physical illness and 3) overall
mortality. Rates of comorbid PTSD and chronic pain are exceedingly high among veterans with reports of 30%-
50% in both Vietnam and OEF/OIF Veterans, that suggest a shared pathophysiology. Excessive release of
peripheral pro-inflammatory cytokines has been implicated in the generation of: 1) pathologic chronic pain states
and 2) in PTSD. Perception of an aversive stimulus/threat activates peripheral inflammatory cytokine release,
while exogenous administration of an inflammatory stimulus (that also cause release of peripheral inflammatory
cytokines) increases the limbic (insular cortex and amygdala) response to aversive/threat stimuli as measured
by functional Magnetic Resonance Imaging (fMRI). Work by our group [Lerman et al., (2016)(15)], shows that
PTSD influences the: 1) nociceptive response, 2) intrathecal cytokine release and 3) peripheral cytokine release
in response to a painful stimulus when compared to responses of Veteran combat controls (CC). Vagus nerve
stimulation has been shown to decrease: 1) peripheral inflammatory cytokine release, 2) pain, and 3) anxiety.
Recent work by our group has shown that non-invasive vagal nerve stimulation (nVNS; using extradermal
stimulation) decreases peripheral inflammation in healthy control subjects and may similarly decrease
hyperinflammation observed in PTSD [Lerman et al., (2016)(22)]. In pilot work, we have obtained initial fMRI
evidence (preliminary data) suggests that in healthy controls, nVNS decreases insular response to painful stimuli,
which is known to be dysregulated in PTSD.
We plan to use nVNS as a probe in PTSD and CC to observe the effects of vagal nerve modulation on: 1) CNS
neural circuit function during pain and pain anticipation stimuli, and 2) peripheral inflammatory biomarker
measures. The long-term goal of this line of research is to use nVNS as a probe to obtain pilot data of: 1)
peripheral inflammatory biomarkers and 2) fMRI derived brain imaging response to pain, to advance our
understanding of fundamental pathophysiology of co-morbid pain and PTSD and to ultimately provide, targeted
neuromodulation based interventions for veterans with pain and PTSD. We will study two groups [(PTSD, CC),
(both without chronic pain diagnosis)], under two conditions (either nVNS or Sham stimulation), over three time
points (pre-nVNS/Sham), (7 days post-nVNS/Sham) and one month after treatment (one month post-
nVNS/Sham). The first objective of this proposal, is to measure peripheral inflammation in response to nVNS
treatment in order to delineate peripheral inflammation based biomarker profiles of treatment responsiveness to
nVNS in PTSD and CC. The second step is to measure brain region response to a pain and pain anticipation
stimuli task before and after nVNS treatment in order to demonstrate: 1) a neural profile of treatment
responsiveness to nVNS and 2) the neural profile of nVNS effects on pain in PTSD and CC. Participants will
receive a 7-day long nVNS/Sham trial where inflammatory biomarkers, neuroimaging tools, PTSD symptom
severity and functional life quality will be assessed before and after the 7 days. Additionally, PTSD symptom
severity and functional life quality will be assessed one month after study onset. The direct contrast of pre and
post nVNS/Sham will provide an objective and sensitive assessment of neuromodulation with nVNS and lay the
groundwork for further neuromodulation based study in PTSD. Such outcomes may provide additional evidence
of potential treatment efficacy, thus ultimately provide therapies that enhance VA clinical practice guidelines.

Public health relevance
The proposal aims to determine if non-invasive vagus nerve stimulation(nVNS) will alter: 1) the peripheral inflammatory biomarker profile, 2) the neural correlates of change in pain stimuli and 3) PTSD symptom severity and 4) life quality and function in Veterans with PTSD. The planned inflammatory biomarker and neuroimaging results can 1) promote knowledge of inflammatory and neurobiological mechanisms that contribute to pain in PTSD, and 2) advance our ability to provide targeted neuromodulation based interventions that support improved life quality and function for Veterans. These goals are consistent with the VA’s mission to sponsor research examining variables related to pathogenesis, diagnosis, and(ultimately) treatment of neuropsychiatric disorders.